High-Throughput, Multiplexing-Ready Intracellular Pressure Probes

PROJECT SUMMARY
It is known that at the level of a single cell, intracellular pressure governs motility, shape, volume, and proliferation.
Mounting evidence suggests that pressure can vary within a single cell and the compartmentalization of pressure
may be essential for dynamic cell function. Thus, it is essential to develop approaches to map the heterogeneous
intracellular pressure within a single cell at submicron resolution given the technical limitations of the current
technology. Specifically, it is challenging to study how intracellular pressure regulates cellular processes, such
as protrusion of the cell cortex, heterogeneously and dynamically, to result in certain phenotypes, such as
directional migration. This challenge stems from the lack of nano-sized sensors that are compatible for high-
throughput multiplexing imaging so that local intracellular pressure and other dynamic processes can be
simultaneously measured across the cell.
Herein we propose to develop a high-throughput, multiplexing-ready intracellular probe in the form of nano-
sized liposomes enclosed by DNA-based scaffold with aquaporin molecules distributed in the lipid bilayer.
Joining the DNA scaffold and the aquaporin-embedded liposome are elastic DNA tethers conjugated with
Foster Resonance Energy Transfer (FRET) donor and acceptor fluorophores at prescribed spacing, which
extend or contract as the result of pressure-dependent changes to liposome volume. The nano-sized pressure
sensor, coined “aquaporin-laced liposome pressure sensor (ALPS)”, will be delivered to the cytoplasm in
quantity. Upon pressure changes in the cytoplasm, the internalized ALPS will change its volume by water efflux
or influx through the aquaporin, while the DNA scaffold stabilizes the liposome to prevent collapse or rupture.
As a proof of concept, we will then use ALPS to map the dynamic pressure field induced within single cells
using compartmentalized pressure to migrate within 3D matrix; the results will be compared to the direct
measurements obtained by 0.5-μm micro-electrodes with limited spatial resolution, the current state-of-art. If
successful, we will generate a novel tool for measuring intracellular pressure with unprecedented
spatiotemporal resolution, which promises to provide insights on how local intracellular pressure changes
dynamically as cells navigate the 3D terrain.

Public health relevance
PROJECT NARRATIVE Mounting evidences suggest that the intracellular pressure is dynamic and heterogeneous across the cell, and cell motility, cell shape, cell size and cell division are regulated the dynamic and heterogeneous intracellular pressure, which cannot be effective mapped with desirable spatiotemporal resolution, due to the lack of adequate sensors. Leverage our expertise in cell biology, DNA nanotechnology and imaging, we propose to develop a nano-sized intracellular pressure sensor, which will be delivered to the cytoplasm and measure local pressure while other cellular processes, such as cytoskeleton dynamics, can be simultaneously measured. If successful, we will generate a novel tool for measuring intracellular pressure with unprecedented spatiotemporal resolution, paving the way to gain insights on how local intracellular pressure changes dynamically as cells navigate the 3D terrain in our proof-of-concept study.